CHILD HEALTH RESEARCH CENTER IN DEVELOPMENTAL BIOLOGY

DESCRIPTION (Adapted from the applicant's description): This is a application for the continued support of the Center of Excellence in Child Health at Washington University School of Medicine. The scientific focus of our Center is to develop and utilize genetic models of human disease states in transgenic and knockout mice. The long-term goal of the Center is to develop Scholars in human developmental biology. This goal is achieved by applying the recent advances in cell, molecular and developmental biology to an understanding of the pathogenesis and treatment of a broad spectrum of diseases within the Pediatric arena. In order to accomplish this established areas of investigative strength of Washington University School of Medicine and the Department of Pediatrics with basic and applied developmental biology will be combined. The Center will continue to utilize the core facility for the generation of animal models of human disease states via new and evolving state-of-the-art technologies.